Leadership & Administrative Core

Leadership Administrative Core (LAC) Project Summary/Abstract
The Leadership Administrative Core (LAC) is responsible for the strategic planning, organization, communication, fiscal management, regulatory functions, and dissemination of findings related to the Pittsburgh Pepper OAIC (Pitt OAIC). The LAC receives valuable input and direction from 5 advisory groups including: 1) the External Advisory Board (EAB) (national experts), 2) the Institutional Advisory Board (IAB) (multidisciplinary group of experts on aging from the University and the Veterans Administration), 3) the Community Advisory Board (CAB) (representatives from local health care agencies, IRB, media, and local leaders), and 4) the Research Education Component (REC) Advisory and the PESC Advisory Committees (both internal and external experts). These advisory groups provide advice and insight to the Executive Committee (EC) composed of OAIC core leadership.
Our specific aims are to:
1. Foster communication and multidisciplinary collaboration among OAIC investigators, cores and projects.
2. Promote awareness and involvement in our work by relevant investigators and research programs in and outside the University of Pittsburgh (Pitt) using various dissemination techniques.
3. Represent the OAIC to other OAICs and the larger academic, NIH, VA, clinical and lay communities.
4. Through the EAB, maintain independent oversight of OAIC processes, resources and progress.
5. Provide research oversight and monitoring for OAIC human studies and establish a DSMB as necessary.
6. Sponsor a Research Seminar series, an Annual Retreat, Workgroups, works in progress, formal internal grant reviews, and new partnership initiatives.
7. Increase basic, clinical and implementation research partnerships.
8. Provide administrative support and manage financial records for the entire Pitt OAIC.
9. Collaborate outside the Institution on OAIC related themes.
For this renewal, through the efforts of the LAC, we create new programs and structures to implement innovative programmatic changes; 1) We greatly expand our partnership with the Veterans Administration (VA) in order to extend our portfolio of age-related mobility and balance research to the Geriatrics Research Education and Clinical Center (GRECC) that serves VISN 4, and 2) We bring new expertise to disseminate and implement our findings in “the real world” through partnerships and collaborations locally, regionally, and nationally through our community and healthcare partners, including the VA. The LAC will be primarily responsible for ensuring all Cores and Workgroups have access to and engage with Pitt resources that focus on implementing evidence-based interventions into practice.